The overlap of speech production and verbal working memory

Abstract
To enable the expression of ideas in everyday conversation, our brain must hold on to speech information for
short periods of time in verbal working memory (vWM). This is particularly important for everyday conversation
that takes place in chaotic environments: Plans for speaking change quickly, and the brain has to adapt to these
changes. Previous models of vWM, have suggested that vWM is anatomically and functionally discrete, with only
indirect interactions with speech production. Evidence from lesions following strokes however, have shown a
wide range of speech production deficits that are also associated with problems with vWM, arguing against a
strong dissociation between speech production and vWM. We propose instead that vWM is integrated in the
speech production planning system, sharing an anatomical and functional substrate. To study this overlap, we
propose to examine neural responses associated with this functional overlap through a population of
neurosurgical patients who as part of their clinical care have electrodes implanted directly in their brain, giving
us a unique opportunity to study the human brain at a greater resolution that has been done in the past. We will
leverage this access to address the following questions: 1) Does speech production and vWM overlap in the
brain? 2) What kind of information is held when planning for speech production? 3) What motor features are
shared between speech production and vWM? We will use a series of tasks that are designed to separate out
the role of vWM for different speech production components and measure human brain responses using direct
brain recordings, including high density electrodes that have unprecedented spatial resolution (<1 mm, up to
1024 electrodes for a 10 x increase in sampling). Understanding this basic cognitive process and their role in
everyday language use will lead to more targeted approaches to help the over 1 million Americans who suffer
from stroke-induced aphasia.

Public health relevance
Project Narrative This project seeks to understand the neural and functional basis of verbal working memory (vWM) for speech production. The dysfunction of vWM has been implicated in both stroke related and developmental language disorders. Understanding the neural and functional basis of verbal working memory for speech production would greatly advance the knowledge of how memory processes support language in the brain, in the hopes that this will lead to more targeted rehabilitation from stroke, better surgical approaches to language mapping, and insight into new therapeutic strategies for speech and language disorders.